Development of a mucosal, polyanhydride-based nanoparticle vaccine for use against RSV infection in the neonate

Project Summary/Abstract
Respiratory syncytial virus (RSV) is a leading cause of severe acute lower respiratory tract infection in infants
and children worldwide. Bovine RSV (BRSV) is closely related to human RSV and a significant cause of
morbidity in young cattle. BRSV infection in calves displays many striking similarities to HRSV infection in
humans, and cattle are an outbred population that is naturally susceptible to BRSV infection. Therefore, BRSV
infection in calves represents an excellent model for studying RSV infection and antiviral immunity in children.
RSV is poorly immunogenic and this has been a complicating factor in the development of a safe and effective
RSV vaccine. Polyanhydride nanovaccines have shown great promise as adjuvants and vaccine delivery
vehicles in rodent models due to their ability to promote enhanced immunogenicity through both the route of
administration and the ability to provide sustained antigen exposure. In a previously funded NIH grant, the
polyanhydride nanovaccine platform was used to develop an efficacious, mucosal nanovaccine that
incorporated the post-­fusion F and G proteins from BRSV. Neonatal calves vaccinated with the BRSV-­F/G
nanovaccine develop virus-­specific cellular and humoral immune responses in the mucosa, and demonstrate
significant reductions in viral burden and disease-­associated pathology. The overall objective of this application
is to improve upon the established efficacy of the polyanhydride nanoparticle platform for use against RSV
infection in the neonate, and to further characterize the mucosal immune responses that correlate with
resistance to RSV infection. The experiments in Aim 1 build upon the established efficacy of the post-­fusion
F/G nanovaccine with the incorporation of additional toll like receptor agonists and modifications to the
mucosal/parenteral inoculation regimen. The experiments in Aim 2 will determine the efficacy of a mucosal
nanovaccine that incorporates the pre-­fusion F and G proteins from BRSV, as well as characterize the
antibody response towards the pre-­fusion and post-­fusion F protein in the respiratory tract of neonatal calves.
The experiments in Aim 3 will determine the duration of immunity induced by polyanhydride nanoparticle
vaccination, while determining the mucosal immune responses that correlate with long-­term resistance to RSV
infection in the calf. Much of our knowledge of RSV infection and immunity stems from studies in rodents and
adult animals;; however, the experiments proposed here will study a natural host-­pathogen interaction and will
examine the response in the neonate, the same population commonly affected by severe RSV disease. We
anticipate that these studies will have a positive impact by identifying a safe and efficacious vaccine for use in
children and animals, and by determining the immune responses that are necessary for long-­term resistance
against RSV infection in the young.

Public health relevance
Project Narrative Respiratory syncytial virus (RSV) is a leading cause of severe acute lower respiratory tract infection in infants and children worldwide. Severe RSV infection as a child is also a significant risk factor for development of wheezing and allergic airway disease later in life. This project uses the neonatal calf model of bovine RSV infection. The objective of the proposed studies is to develop an efficacious, mucosal, nanoparticle vaccine for use against RSV infection in neonates;; and to identify cellular and humoral mucosal immune responses that correlate with resistance to RSV infection.